EFFECTS OF GLUCOCORTICOID ADMINISTRATION ON TSH SECRETION

TSH is secreted in discrete pulse and has circadian variation. The origin of the tsh pulses is unknown. This protocol will determine whether cortisol infusion alters TSH pulse amplitude or frequency.